Multimodal profiling of stress-induced immune reprogramming in cardiovascular patients

SUMMARY
Chronic psychosocial stress is a pervasive component of the human experience, carrying an attributable
cardiovascular disease (CVD) risk that is on par with smoking or cardiometabolic disease (CMD). While a
“heart-brain connection” has long been postulated, the mechanisms underlying stress’s deleterious effects on
the cardiovascular system are largely under-investigated. In the previous grant cycle, we used cutting-edge
tools, including combined positron emission tomography and magnetic resonance (PET/MR) imaging, to gain
critical insights on the links between severe, acute psychosocial stress and altered neural, immune, and
cardiovascular functions in post-traumatic stress disorder (PTSD) patients with low CVD risk. In the course of
this first Program Project, our landmark findings uncovered a stress-associated neuro-immune-cardiovascular
axis, which has now been validated by several other groups and proven to be a pervasive promoter of
cardiovascular diseases. As shown by our preliminary data, we also observed strong links between stress-
associated neural activity (SNA) and several CMD components, and we showed that genetics and lifestyle
factors can modulate the relationship between stress and CVD. However, critical knowledge gaps remain. We
need a better understanding of how stress-induced disruptions in neural networks lead to immune system
dysregulation, CMD and atherosclerosis. The mechanisms by which genetic and lifestyle factors impact the
neuro-immune-cardiovascular axis are also not well understood. Moreover, these processes need to be
studied in individuals at higher risk for cardiovascular disease, the same population that would stand to gain
the most from insights on how best to modulate this system to improve cardiovascular health. The
overarching hypothesis of Project 4 is that, in subjects with moderate-to-high risk for CVD: heightened SNA
(notably including the activity of the the amygdala and ventromedial prefrontal cortex (vmPFC)) associates with
CMD, heightened immune system activity, and, ultimately, CVD manifestations. We hypothesize that this
stress-related neuro-immune-cardiovascular axis is modulated by genetic traits and health behaviors that are
known to associate with stress sensitivity. In the first aim of this Project, we will focus on characterizing stress-
related alterations in neurological networks that associate with CVD and CMD, in the context of genetic and
health behaviors. The second aim will characterize the stress-induced immune dysregulations that mediate
CVD. In summary, this study will provide critical insights into the connections between stress-induced
alterations in brain circuitry, immune dysregulations, and their downstream deleterious consequences on the
cardiovascular system in patients at moderate-to-high risk for CVD. By exploring the interactions among these
processes and other important CVD risk factors, such as cardiometabolic, genetic, and lifestyle factors, we will
be able to shed light on novel strategies to mitigate stress’s negative effects on the cardiovascular system.